A Novel Strategy to Inhibit Candida glabrata Virulence by Targeting an Essential Fungal Lipid Transfer Protein

PROJECT SUMMARY
Candida glabrata is a pathogenic fungus in human infectious disease that has acquired antimicrobial resistance,
which contributes to the significant mortality rate of 47% in cases of invasive candidiasis (systemic infection).1–5
To help address this threat, the proposed work investigates a novel strategy for interfering with the lipid signaling
pathways required for viability and virulence of Candida glabrata. The proposal rests on: (i) the discovery of a
novel class of small molecule inhibitors (SMIs) of four chemotypes directed against the fungal lipid-binding
protein SEC14 and (ii) the idea that SEC14 is a compelling target for next-generation antimycotics that offers
the capability to interfere with essential phosphoinositide signaling pathways in a specific way that does not
involve targeting the highly conserved enzymes of these signaling pathways. Whereas the actions of these SMIs
against the SEC14 of Saccharomyces cerevisiae has been studied, there is little information regarding the
efficacies of these SMIs in targeting the SEC14 proteins of pathogenic fungi. Candida glabrata provides a direct
path to testing the idea that targeting SEC14 is a viable strategy for developing next-generation antimycotic
drugs. This project addresses: (i) the antimycotic potential of SEC14-directed SMIs against Candida glabrata,
(ii) their potencies, (iii) the biochemical and structural basis for how these SMIs inhibit C. glabrata SEC14
proteins expressed by clinical isolates, (iv) the cellular consequences of SMI treatment in both planktonic and
community (biofilm) settings, and (v) their efficacies in inhibiting virulence activities of C. glabrata. Given my
career interests in internal medicine, this project will provide a deeper understanding of the approach to drug
resistance in infection, a serious clinical problem on the medicine ward.6

Public health relevance
PROJECT NARRATIVE Multidrug resistant Candida, including Candida glabrata, present a rising public health crisis due to the high mortality of invasive candidiasis – a systemic consequence of inadequately treated Candida infection. The goal of this work is to address the prospect of developing new antimycotic compounds that inhibit fungal phosphoinositide signaling pathways with very high specificity. In agreement with the National Institute of Allergy and Infectious Diseases mission statement to “conduct and support basic and applied research to better understand, treat, and ultimately prevent infectious, immunologic, and allergic diseases,” this work aims to set the preclinical foundation to prevent a life-threatening infectious disease.